Carotid Revascularization and Medical Management for Asymptomatic CarotidStenosis Trial - Hemodynamics (CREST-H)

CREST-H Project Summary
Cerebral hemodynamic failure in patients with high-grade carotid artery stenosis can impair cognition even if
no overt clinical stroke has occurred, contributing independently to cognitive decline either directly or
because of a higher occurrence of silent infarction. CREST-H addresses the compelling question of whether
carotid revascularization can stabilize or reverse cognitive decline in a subset of patients with asymptomatic,
high-grade carotid stenosis who have cerebral hemodynamic failure related to the carotid stenosis. Although
there is mounting evidence from preclinical and clinical studies that hemodynamic impairment affects
cognition in patients with carotid occlusive disease, treatment of this condition has never been tested in a
randomized clinical trial. CREST-H has just passed 65% of target enrollment, a process slowed by the
pandemic. This grant renewal will allow us to complete the (revised) target enrollment for CREST-H.
Randomization in CREST-H is done within the parent trial, CREST-2, which comprises a pair of outcome-
blinded, Phase 3 clinical trials in patients with asymptomatic high-grade carotid artery stenosis, comparing
stroke prevention and death for either carotid endarterectomy (CEA) or carotid artery stenting (CAS) plus
intensive medical management (IMM) versus IMM alone. CREST-2 has just received notice of funding for an
additional 5 years. Hemodynamic impairment is measured by an inter-hemispheral MRI or CT perfusion “time
to peak” (TTP) delay on the side of stenosis. Patients with baseline hemodynamic impairment return for
follow up brain imaging at 1 year. For those who are found to have baseline hemodynamic failure and
cognitive impairment, the cognitive batteries at baseline and at 1 year will determine if those who are
assigned to a revascularization arm in CREST-2 will have better cognitive outcomes than those in the
medical-only arm. That treatment difference will be compared with the treatment difference among those who
have no flow failure, that is, there will be a significant flow-failure-by-treatment interaction. We postulate that
hemodynamically significant “asymptomatic” carotid disease may represent one of the few examples of a
treatable cause of cognitive impairment. If cognitive decline can be arrested in these patients, then we will
have established a new indication for carotid revascularization independent of the risk of recurrent stroke.

Public health relevance
PROJECT NARRATIVE The demonstration that some patients with carotid artery stenosis are living with preventable cognitive impairment has significant public-health impact. The estimated prevalence of asymptomatic, severe, carotid artery stenosis is 2% of the general population over age 60, or 124,000 people in the US alone in 2010. Extrapolating from a Canadian study that estimated per patient costs of vascular cognitive impairment, if even 10% of these patients had cognitive dysfunction, annual societal costs could be as high as $2.5 billion.